Retinoid cycles and retinal disease treatment

Project Summary
Age-related macular degeneration (AMD) is a major cause of legal blindness in individuals over 60 years old
including Veterans. It is characterized by central field vision loss where sharp, polychromatic images are formed
under the well-lit conditions in which modern humans are immersed, which leads to significant disability. The
high prevalence of AMD places a heavy burden on the healthcare system with upwards of 98 billion dollars spent
yearly on AMD-related healthcare costs in the US. Currently, there are no highly effective treatments for the most
common form of the disease, known as geographic atrophy, which makes up ~90% of advanced AMD. During
the past VA funding period, we studied visual cycle modulation and phosphodiesterase inhibition as potential
treatments for AMD and developed a novel mouse model to study a critical tissue involved in AMD pathogenesis.
Based on key findings we made during this funding period, we now propose to investigate details of retinoid
physiology and develop new retinoid-based treatments for retinal diseases including AMD. We can now
quantitatively interrogate and define the cell-specific functions of retinoid-binding proteins and enzymes with
multiple sites of expression within the body and leverage this information to more fully understand how to
provide therapeutic benefits to Veterans suffering from retinal diseases. We will pursue these objectives through
the following Aims: 1) Define cell-specific roles of cellular retinaldehyde-binding protein (CRALBP)
in visual chromophore synthesis and photoreceptor function. CRALBP is a retinoid-binding protein
that contributes to visual cycle function and is involved in a variety of retinal diseases. It is expressed in both the
RPE and Müller glia cells of the retina. Data suggest these two pools of CRALBP play different roles in retinal
physiology, but studies performed to date have produced conflicting results. Taking advantage of newly
developed tissue-specific CRALBP knockout mice, we will investigate the role of this protein in photoreceptor
function and retinal structure using a host of sophisticated electrophysiological, biochemical, and retinal imaging
techniques. Our data are expected to provide critical information about tissue targeting for gene therapy
approaches. 2) Evaluate the roles of lecithin:retinol acyltransferase (LRAT) in ocular retinoid
homeostasis. LRAT is an enzyme critically involved in an ocular retinoid trafficking axis existing between the
gut, the liver, and the RPE. This protein plays a key role in retinoid storage in the liver and is also crucial for
visual function. Several outstanding questions remain regarding cell-specific functions of LRAT in determining
retinoid distribution and maintenance within the eye. We will clarify the roles of LRAT in the RPE and the liver
through tissue-specific LRAT knockout studies. We hypothesize that LRAT is crucial for both packaging of
retinoids in the liver for delivery to the eye as well as retention of retinoids within the RPE following delivery.
These models also allow us to assess the importance of alternative retinyl ester-forming enzymes in supporting
visual function. 3) Advance cis-retinoids as potential treatments for retinal diseases. Dysregulated
retinoid homeostasis is involved in various aspects of age-related vision decline including AMD. One
troublesome symptom of this condition, which also predicts disease progression, is a deficit in dim-light vision.
It is believed that this loss of visual function arises from impairments in visual cycle function, suggesting that
external retinoids may be effective treatments. Indeed, prior clinical studies have shown a beneficial effect of
retinoid supplementation on visual function in AMD patients. We recently demonstrated that a derivative of
vitamin A, 9-cis-retinyl acetate, is highly effective in restoring both peripheral and central visual pathways in
adult mice with a severe retinoid deficit. We will study the impact of retinoid supplementation on visual function
and retinal health as well as the mechanisms for cis-retinoid distribution to the eye. These studies are expected
to provide key proof of concept data for further investigations of cis-retinoid treatments in Veterans.

Public health relevance
Project Narrative Age-related macular degeneration (AMD) is a debilitating blinding disease of older age that is prevalent in the Veteran population. Although perturbed vitamin A and ocular retinoid metabolism have been implicated in AMD pathogenesis, limitations in our understanding of these pathways has hampered efforts to therapeutically intervene in this disease. The goal of this proposal is to genetically or pharmacologically modulate pathways linked to vitamin A metabolism and retinal disease pathogenesis to gain insights necessary for development of novel therapies to treat retinopathies including AMD.